Cancer Control Program

CANCER CONTROL (CC) PROGRAM: SUMMARY
The HCC Cancer Control (CC) Program continues to foster transdisciplinary population science research to
reduce cancer morbidity and mortality and eliminate disparities in South Carolina and beyond. Program Aims
are to: (1) Investigate biological, behavioral, and health systems-related risk factors for cancer occurrence and
its consequences, (2) Develop, evaluate, and translate novel interventions that modify risk behaviors, reduce
mortality, improve quality of life, and enhance survivorship, and (3) Examine individual, community, and
system-level barriers and facilitators that influence the delivery, uptake, and adherence of cancer prevention
and control interventions. Research Highlights: The Program offers sustained thematic strength in cancer
health disparities and tobacco control and has achieved significant growth in the areas of early detection and
survivorship. Impactful research ranges from the discovery of novel biomarkers to understand cancer
disparities, to innovative tobacco cessation trials among diverse populations and settings, to survivorship trials
to advance cancer care delivery. Impact: The CC Program has achieved significant growth across all metrics,
reaching its highest levels for NCI funding ($5.2M; 475% increase), and peer-reviewed cancer-relevant funding
($6.6M; 187% increase), leading to 524 cancer-relevant publications (186% increase), of which 21% were
within high impact journals (IF>10), and 49% were published in collaboration with other HCC members. CC
members have received $670k in intramural pilot grant funding support from HCC, which resulted in $18.6M in
peer-reviewed funding, a 27.5-fold return on investment. The impact of CC research is equally impressive, with
a range of policy-shaping, practice-changing, and/or paradigm-shifting studies. Through bidirectional
engagement with Community Outreach and Engagement, CC research reaches across the catchment area.
Expansion of CC science through the newly acquired health systems within the Regional Health Network helps
to ensure relevance and responsivity to community needs. Members: CC membership increased to 38
members from 11 departments, with 17 women and six members who identify as an underrepresented minority
(URM). The program is co-led by Matthew Carpenter, PhD, and Ashish Deshmukh, PhD, national leaders in
tobacco control, cancer screening, and decision science. Program activities/initiatives: With significant HCC
support, CC has set a foundation for three new initiatives to increase program synergy and value to HCC, as
well as to extend the impact of its research across SC and beyond 1) a newly developing Social Determinants
of Health Shared Resource (SHARE), 2) a focused initiative on Survivorship and Cancer Outcomes Research
(SCOR) to guide faculty recruitment, and 3) the South Carolina Center for Health Equity (SC CHEQ) to extend
the geographic reach of CC research. These programmatic priorities closely align with the strategic priorities of
the HCC, further positioning the CC Program to conduct compelling and innovative research that aims to
prevent cancer and its consequences and to advance cancer health equity and care delivery.